Experimental Study of a Model to Support Research Evidence Use for Protecting Children

Project Summary
Protecting children through the primary prevention of child abuse and neglect (CAN) is a major priority given that
an estimated 1 in 7 children are affected each year in the U.S. and the societal cost of CAN is of over $400
billion. Even though there are many evidence-based programs to prevent abuse, reduce harm, and treat trauma,
there remain numerous barriers for policymakers to craft scientifically-informed policies to protect children.
Accordingly, we propose an experimental study of a formal, theory-based approach for supporting policymakers’
use of scientific evidence that does not involve lobbying—the Research-to-Policy Collaboration (RPC) Model.
The RPC fosters productive engagement between the policy and research communities by implementing
systematic capacity building and outreach strategies. Previous experimental work on the RPC demonstrated the
ability of this model to increase engagement between researchers and policymakers, increase policymakers’
value for research evidence, and improve their use of scientific evidence in their policymaking. We propose a
state-level randomized controlled trial of the RPC (N = 30 state legislatures) that will evaluate the model’s ability
to improve engagement between state policymakers and the science community, build policymakers’ awareness
and value of CAN research, and subsequently increase their use of research evidence throughout the
policymaking process. To accomplish this, we will test three specific research aims. Aim 1 will assess historical
and current use of research evidence in state legislation pertaining to policies to protect children and provide
equitable service delivery. This will involve qualitative coding of bills introduced by state legislatures over the last
five years. Aim 2 will compare the frequency and quality of engagement with CAN researchers between the
intervention and control conditions. Additionally, we will assess how the RPC model influences policymakers’
value and awareness of CAN research and evidence-based programs over time using a validated survey across
three time points. Aim 3 will evaluate the effectiveness of the RPC on legislators’ actual use of research in
legislation by observing and quantifying changes in legislator behavior related to research use. Improving the
use of scientific information in policymaking can reduce population-level CAN and protect children by increasing
the availability of evidence-based prevention programs and policies.

Public health relevance
Public Health Relevance: To successfully attain population health benefits from CAN research, state policies that incentivize and facilitate the use of this evidence in programs and practices are needed. This study aims to transform the access of CAN research for state policymakers by building their capacity to connect with a national network of CAN researchers. We hypothesize the intervention will increase policymakers’ awareness and value of CAN research, and ultimately their introduction of evidence-informed policies.